EFFECTS OF ETHNICITY ON CYTOCHROME P450 IN HLTHY INDIVS USING MIDAZOLAM

There is little available data on the effects of ethnicity on drug disposition. Understanding the activity of the cytochrome P450 3A4 enzyme (CYP3A4) is important to the metabolism of a wide variety of xenobiotics. Midazolam has recently been studied as an attractive in vivo probe for CYP3A4. The pharmacokinetics of oral and intravenous midazolam will be studied in twenty-four healthy African-American and Caucasian individuals.